Characterization of Multiple Factors in Training and Plasticity in Central Vision Loss

Project Summary
Research on perceptual learning (PL) has been dominated by studies that seek to isolate and improve individual
visual processes. However, an important translational outcome of PL research is to address the needs of patients
with vision loss, who seek to improve performance on daily tasks such as reading, navigation, and face
recognition. These more ecological cases of behavioral change and cortical plasticity, which are inherently
complex and integrative, have revealed significant gaps in a more holistic understanding of how multiple visual
processes and their associated brain systems jointly contribute to durable and generalizable PL. To address
these gaps, here we study simulated and natural central vision loss. We focus on macular degeneration (MD),
one of the most common causes of vision loss (projected to affect 248 million people worldwide by 2040), which
results from damage to photoreceptors in the macula that disrupts central vision. Such central vision loss is a
superb lens through which study to how ecologically relevant changes in the use of vision relate to changing
brain activity and connectivity because it represents a massive alteration in visual experience requiring reliance
on peripheral vision for daily tasks. With the use of eye-trackers and gaze-contingent displays that induce central
scotomas, central vision loss can be simulated in normally seeing individuals, who then develop peripheral
looking patterns that resemble compensatory vision strategies seen in MD patients. Ideal use of peripheral vision
requires improvement in multiple vision domains, three of the most important being: early visual processing (e.g.,
visual sensitivity), mid-level visual processing (e.g., spatial integration), and attention and eye-movements. To
date, no study has systematically investigated these three domains of PL and their neural underpinnings. The
proposed research plan rests on rigorous prior work showing that PL influences multiple brain structures and
functions related to these three domains. We propose a novel approach of systematically measuring how
different training regimes related to the three domains influence a broad range of psychophysical and ecological
behaviors (Aim 1), how these changes arise from plasticity in brain structure and function (Aim 2), and how PL
after simulated central vision loss compares to PL in MD (Aim 3). This work is significant and innovative as it will
be the first integrated study of PL characterizing multiple trainable factors and their impact on diverse behavioral
outcomes and on cutting-edge assessments of neural representations and dynamics. It is also the first study to
directly compare PL in MD patients with PL in a controlled model system of central visual field loss with simulated
scotomas, which if validated will allow the use of this model system to interrogate MD in larger samples of healthy
individuals. We will also share a unique dataset that will help the field to understand behavioral and neural
plasticity after central vision loss and individual differences in responsiveness to training. Finally, this work will
illuminate basic mechanisms of brain plasticity after sensory loss that may generalize to other forms of
rehabilitation after peripheral or central damage.

Public health relevance
Narrative The proposed research is relevant to public health because a greater understanding of plasticity after central vision loss can inform new therapies for treating low vision and has potential to benefit millions of individuals suffering from low vision. The treatment of low vision is particularly relevant to the mission of the NEI to support research on visual disorders, mechanisms of visual function and preservation of sight. The comparison of dif- ferent training and outcome factors is in line with the NIMH RDOC framework and studies in an aging popula- tion are consistent with the mission of the NIA.